Novel pre-coital, non-hormonal multipurpose prevention technology (MPT)

ABSTRACT
Emerging evidence indicates that women are more likely to use a multipurpose prevention technology (MPT) for
pregnancy and HIV/STI infection prevention than a product for pregnancy or HIV/STI infection prevention. The
MPT development space is dominated by products that contain one or more hormonal contraceptives, which
many women, including breastfeeding women, cannot or will not use. Amphora gel is an exception. Ampphora
is a non-hormonal, vaginally-acting contraceptive product for women being developed by Evofem Biosciences
Inc. It works by maintaining a low vaginal pH that is hostile to sperm, bacteria, and viruses. Evofem recently
completed a Phase 3 contraceptive efficacy trial of Amphora that indicated typical use efficacy of 86.0% and per
protocol efficacy (perfect use) of 98.7%, comparable to the efficacy of the most commonly used forms of
hormonal contraception, oral pills. Amphora is currently being tested in Phase 2b trials for prevention of
urogenital chlamydia and gonorrhea in women and preparing for trials for prevention of recurrent bacterial
vaginosis (BV), which has completed enrollment. QGRFT is a stable analog of the non-antiretroviral (non-ARV)
anti-HIV lectin griffithsin (GRFT). We completed a Phase 1 trial of a vaginally administered GRFT gel, and
with PATH developed a novel vaginally administered GRFT fast dissolving insert (FDI) that significantly
prevented simian human immunodeficiency virus (SHIV) infection in macaques and HSV-2 and HPV infection in
mice. Our long term goal is to develop an Amphora/QGRFT FDI for adolescent girls and a wide range of women,
including breastfeeding women, which provides non-hormonal contraception and reduces the risk of acquiring a
broad range of viral and bacterial STIs. Herein we will evaluate the feasibility, safety, and in vivo efficacy of two
innovative MPT prototypes: an Amphora/QGRFT FDI that could have contraceptive and anti-HIV/STI/BV
properties and an Amphora-only FDI that could have contraceptive and anti-STI/BV properties. The
prototypes will be manufactured and then evaluated in a series of in vitro assays, physiochemical
property/stability evaluations, and in vivo studies to demonstrate FDI disintegration, drug retention in the vagina,
safety, anti-HIV activity (pharmacodynamics studies in a macaque model and in vivo efficacy in macaques) and
anti-HSV-2 activity (murine model). The Amphora/QGFRT FDI may offer more potent anti-HSV-2 activity than
Amphora alone due to QGRFT’s anti-HSV-2 activity. Using data obtained in these studies, we will select one FDI
to advance into contraceptive efficacy testing in rabbits and IND-enabling toxicology studies in rats. The novel
non-hormonal FDI proposed here could (i) eliminate side effects associated with hormonal contraceptives, (ii)
meet the needs of women who have infrequent sex or who are breastfeeding, and (iii) reduce the sexual
acquitision of HIV/STIs and the emergence of ARV-resistant HIV. This woman-initiated FDI has the potential to
improve women’s health and advance the MPT field. When approved, the FDI would be the first non-hormonal,
on-demand and event-driven MPT with both contraceptive and broad spectrum anti/HIV/STI properties.

Public health relevance
PROJECT NARRATIVE We plan to develop a pre-coital, on-demand fast dissolving insert (FDI) containing a safe and effective combination of a nonsteroidal contraceptive and a potent anti-HIV/STI agent to protect women from pregnancy and the sexual acquisition of HIV/STIs. We expect this unique product will be used by women who have concerns about side effects from hormonal contraceptives, infrequent sex, and risk of HIV/STI acquisition.